Structure and dynamics of G protein coupled receptor-G protein complexes

DESCRIPTION (provided by applicant): The goal of this proposal is to determine the structural basis by which G protein-coupled receptors (GPCRs) activate specific G proteins. The majority of hormones and neurotransmitters communicate information to cells via GPCRs, and GPCRs represent the largest group of targets for drug development. Our laboratories have a long-standing interest in elucidating the structure and mechanism of G protein activation by GPCRs. During the previous funding period we succeeded in obtaining the first crystal structure of a GPCR-G protein complex: the beta2 adrenoceptor (β2AR) in complex with Gs, the stimulatory protein for adenylyl cyclase. This structure provides important mechanistic insight into G protein activation, but at the same time raises new questions that will be addressed in this competitive renewal. Specific Aims include: Aim 1. Determine the structural basis of GPCR-G protein coupling specificity. The structure of the β2AR-Gs complex provided the first high-resolution insights into transmembrane signaling by a GPCR. However, additional GPCR-G protein complexes will be required to understand the structural basis for G protein coupling specificity, and to determine if the mechanistic insights obtained from the β2AR -Gs structure are generalizable to other GPCR-G protein pairs. We therefore propose to obtain three additional GPCR-G protein complex structures: (1) the vasopressin receptor-Gs complex; (2) the structure of the β2AR-Gi complex; and (3) the structure of the M2R-Gi complex. Aim 2. Characterize the formation of the β2AR-Gs complex from the GDP bound Gs heterotrimer. The β2AR- Gs crystal structure represents a single state in a complex cycle of events. The process of complex formation and dissociation remains poorly understood. These are dynamic process that may not be addressable by crystallography; however, the β2AR-Gs structure will provide the basis for designing and interpreting biochemical and biophysical studies to characterize the mechanism of complex formation and dissociation. In Aim 2 we will characterize the low affinity interactions between the β2AR and GDP bound Gs. These interactions may play a role in G protein coupling specificity. Aim 3. Characterize the process of β2AR -Gs dissociation following GTP binding. The goal of this Aim is to understand how the β2AR -Gs complex dissociates into active signaling proteins upon binding GTP and to identify persisting interactions between any of the three components: β2AR, Gαs and Gβγ. Aim 4. Characterize the dynamic behavior of the Gαs alpha helical domain. The most surprising and unexpected feature of β2AR-Gs structures is the flexible link between the two domains that make up Gαs: the Ras-like GTPase domain and the alpha helical domain (AHD). This subaim will further characterize the interactions between these two domains in the β2AR-Gs complex as well as in GTP and GDP bound states.

Public health relevance
The goal of this proposal is to determine the mechanism by which G protein coupled receptors (GPCRs) activate specific cellular G proteins in response to hormones and neurotransmitters, and modify the function of cells. This information will facilitate the process of drug discovery for GPCRs, which are the largest family of membrane proteins in the human genome. Drugs acting on GPCRs can have an impact on a broad spectrum of diseases including: cardiovascular disease, pulmonary disease, inflammation, diabetes and obesity, behavioral disorders and Alzheimer's disease.